Comp A: Texas BD-STEPS III Core

PROJECT SUMMARY
Birth defects are a major contributor to infant mortality, morbidity, and healthcare costs in the U.S., but the
etiologies of these conditions remain unknown for most individuals, which has hindered development of
population-level prevention strategies. Thus, a critical next step in the national birth defect research agenda is
to better understand the parental and infant determinants of these conditions to identify and implement
strategies to reduce birth defect-related morbidity and mortality. As a founding member of the National Birth
Defects Prevention Study (i.e., the predecessor of the Birth Defects Study to Evaluate Pregnancy exposureS
(BD-STEPS), the Texas Center for Birth Defects Research and Prevention has helped advance birth defects
research and prevention since the founding of the Texas Birth Defects Registry in 1996. The Center represents
a collaboration between the Texas Birth Defects Registry at the Texas Department of State Health Services,
UTHealth School of Public Health, and Baylor College of Medicine. The addition of our geographic region to
BD-STEPS recruitment pool would allow for increased diversity, particularly among Mexican Americans, one of
the fastest-growing racial/ethnic groups in the U.S. By leveraging one of the largest birth defects registries in
the world, our team has extensive experience in birth defects surveillance and epidemiology, and an
exceptional track-record for both generating publications (N>500) that have contributed toward elucidation of
birth defects risk factors and training the next generations of birth defects researchers. Building upon our
strong infrastructure for patient recruitment, data collection, and epidemiologic analyses, we now propose to
contribute our experience and resources to BD-STEPS by collaborating with our long-term partners from other
states to advance the study’s data collection and impact, through research and training. Our Center’s particular
research areas include 1) social determinants of health (led by the Texas Department of State Health
Services); 2) genetic risk factors (led by Baylor College of Medicine); and 3) occupational exposures (led
by UT Health School of Public Health). Thus, we are well-positioned to conduct, publish, and present at least
seven proposed research studies designed to identify associations with these and other exposures in BD-
STEPS and to improve understanding of the specific mechanisms that underlie risk for particular birth defects.
At its conclusion, we expect this work will have expanded the list of potentially modifiable maternal exposures
that are known to be associated with the risk of birth defects, contributed new knowledge that will aid in the
design of risk reduction strategies, and empower the development of doctoral and post-doctoral trainees and
junior faculty members. Most importantly, it is expected that these outputs will ultimately translate to a
reduction in the prevalence of birth defects and improved health among infants born with these conditions.

Public health relevance
Project Narrative While birth defects are the number one cause of mortality, disability, and medical expenditures within the first year of life, their etiology is unknown in most affected individuals, and most research in the U.S. has focused on populations with relatively limited diversity (e.g., primarily non-Hispanic white subjects). To address this gap, the Texas Center for Birth Defects Research and Prevention proposes to contribute our diverse population to BD-STEPs, as well as our team’s experience and resources as one of the largest birth defects registries in the world, and as national leaders in birth defects surveillance, research, and training of the next generation of birth defects epidemiologists. By growing our ongoing collaborations with our partners at the CDC and NBDPS/BD-STEPS Centers, we expect to identify modifiable genetic and non-genetic risk factors for birth defects with important implications for future prevention strategies designed to reduce risk for birth defects and improve health among affected individuals.